Identifying Predictors of Condom Use

Project Summary
Black adolescents are disproportionately at risk of negative sexual health outcomes, such as HIV and other
sexually transmitted infections (STIs), compared to their peers. Condoms are an effective preventative
measure for adolescents, as they are more accessible than other forms of HIV prevention (e.g., pre-exposure
prophylaxis) in addition to being the only form of contraceptive that reduces the risk of both STIs and
unintended pregnancy. However, condom use among Black adolescents is particularly low, with Black
adolescents reporting lower condom use at last intercourse than White and Hispanic adolescents. Black
individuals face interpersonal experiences (e.g., racial discrimination) and structural inequities (e.g., healthcare
and condom access) influential to their condom use decisions. Adolescent condom use decisions may also be
influenced by the rapid biological changes taking place during this developmental period and the navigation of
romantic and sexual relationships for the first time. Prior literature has mostly focused on individual-level (i.e.,
individual attributes) predictors of condom use, finding somewhat conflicting results and neglecting the
structural, environmental, and contextual predictors influential to condom use for this age group. Thus, the
purpose of this study is two-fold: (1) to use meta-analytic methods to systematically review and statistically
synthesize the literature surrounding individual-level predictors of condom use for Black adolescents (Aim 1)
and (2) to use in-depth individual interviews to address the gaps in prior literature surrounding the role of
structural, contextual, and environmental factors in condom use among Black adolescents (Aim 2). The
proposed study will utilize the Multiple Domain Model of Condom Use, a model outlining both the cognitive
decision-making around condom use, as well as the socio-structural, environmental, and contextual factors
influential to condom use, as a framework to address multilevel predictors of condom use decisions amongst
this population. Through conducting this F31 study in coordination with the proposed training activities, the F31
PI will meet the following training goals: 1) gain proficiency in meta-analytic techniques; 2) gain proficiency in
qualitative research methods; 3) gain theoretical and empirical knowledge of the health disparities experiences
by Black adolescents; 4) develop expertise in adolescent sexual health and behaviors; and 5) build publication
record, presentation skills, and professional network through professional development training, all of which will
aid in their goal of becoming an independent researcher.

Public health relevance
Project Narrative Black adolescents are disproportionately at risk for negative sexual health outcomes, including HIV and other sexually transmitted infections, and often report low rates of condom use, a preventative measure that may reduce these negative outcomes. This F31 study will synthesize the literature and explore the social determinants of health as they relate to Black adolescent condom use decisions. Using both quantitative (i.e., meta-analysis) and qualitative methods, this study will identify predictors of condom use at the individual, contextual, structural, and environmental levels, information necessary to address the significant sexual health disparities faced by this population.